R21: Promoting Adaptive Decision-Making in Schizophrenia Through Improved Evidence Integration: A Combined Neuroimaging and Experience Sampling Study

PROJECT SUMMARY/ABSTRACT
Schizophrenia (SZ) is a chronic condition characterized by cognitive impairment, atypical beliefs, and reduced
reward/goal pursuit, which contribute to ongoing functional impairment even when other active phase
symptoms subside. Symptom severity has been associated with poor decision-making with respect to integrating
information about potential rewards and associated uncertainty, often manifesting as maladaptive unwillingness
to tolerate the risk of failure. This risk-aversion limits opportunities to gain new or additional rewards or
resources (i.e., nothing ventured, nothing gained). How an individual attends to and accrues information
critically impacts subsequent decisions. While research has identified neural circuits implicated in impaired
decision-making during choice in SZ, less is known about the processes by which information is attended to and
accrued from the environment and integrated before a choice is made. This project will identify how decision-
making in SZ is impacted by attentional, behavioral, and cognitive processes preceding decision choice, and
whether associated neural signals predict daily, real-world decisions. Isolating these antecedents of impaired
decision-making allows for the implementation of ameliorative interventions, empowering those with SZ to make
choices that could reduce the burden of illness.
First, leveraging concurrent functional magnetic resonance imaging (fMRI) and eye-tracking, the project will
characterize attentional processes underlying evidence integration prior to decision choice. It will determine if
SZ is associated with visual attentional biases toward aversive, and away from potentially rewarding, stimuli, and
whether these biases underlie differences in associated brain activation in regions such as the nucleus accumbens
(NAcc), insula, and anterior cingulate. Second, during fMRI it will test whether implementing cognitive strategies
prior to decision-making upregulate reward-related brain activation and ameliorate disadvantageous choice in
SZ. During upregulation via cognitive strategies, those with SZ are hypothesized to improve decision-making
while increasing connectivity between NAcc and prefrontal regions, and during decision-making they are
predicted to exhibit increased NAcc activation underserving adaptive reward pursuit. Such a result would suggest
the feasibility of teaching these strategies as a clinical intervention for excessive risk aversion. Third, real-world
daily behavior will be assessed using experience sampling methods to ascertain how daily decisions are impacted
by perceived risks and symptom expression. Those with negative symptoms are predicted to endorse greater
perceived risk of failure before potential activity engagement and those with positive symptoms are predicted to
have less perceived risk of failure, despite impaired engagement. Finally, combined data will establish whether
brain activation and task behavior predict real-world decisions to pursue rewards despite potential risk of failure.
The project will establish the foundation for a novel interventional program of research into improving decision-
making in SZ by elucidating distinct targets of behavioral and neuromodulatory intervention.

Public health relevance
PROJECT NARRATIVE Schizophrenia is the 8th leading cause of disability world-wide and is associated with impaired decision-making related to difficulty processing information about choices that lead to potentially rewarding outcomes relative to potentially detrimental outcomes. The project leverages neuroimaging, eye-tracking, and daily experience monitoring to identify how attentional biases and the application of cognitive strategies impact decisions, and how activity in coordinated brain regions during evidence integration relate to real-world decision-making problems in people with schizophrenia. The results will guide interventions to empower those with schizophrenia to improve their decision-making capacity.